Mapping somatodendritic circuits of midbrain dopamine neurons

Project Summary
The mesocorticolimbic dopamine (DA) system plays a central role in the acquisition of behaviors reinforced by
drugs of abuse. Dopamine neurons in the midbrain substantia nigra pars compacta (SNc) and ventral tegmental
area (VTA) innervate a vast number of terminal regions to mediate diverse functions such as locomotion, reward
encoding, and motivation. Because DA neurons largely project to a single terminal site, they form distinct non-
overlapping populations involved in different functions in predominantly separate circuits. Previous work has
shown that DA cells can locally modulate the excitability of neighboring DA neurons via somatodendritic
dopamine release, which acts on inhibitory D2 autoreceptors located on the soma and dendrites of DA neurons.
This inhibition regulates midbrain dopamine neuron firing and thus regulates the amount and timing of dopamine
released at downstream projection sites. Furthermore, recent work has found that somatodendritically released
dopamine acts in a localized point-to-point manner, as in synaptic transmission. This evidence and the fact that
DA populations form discrete circuits, raises the likelihood that there exists a specific pattern of somatodendritic
connectivity between projection-specific DA populations. Because the local circuitry between pre- and post-
synaptic DA neurons within the VTA and SNc is unknown, the role of somatodendritic signaling in integrating
diverse afferents and shaping output signals to target sites is unclear. Additionally, since glutamatergic inputs
drive dopamine neuron burst firing, they regulate both terminal and somatodendritic DA release. The use of
drugs of abuse is known to alter glutamatergic inputs on DA neurons, thus studying the pattern of somatodendritic
inhibition driven by glutamate inputs could provide insights into circuit mechanisms that can dampen DA signaling
and curb the reinforcing properties of drugs of abuse.
The goal of this proposal is to determine the local somatodendritic circuitry that modulates the activity of
dopamine populations within the midbrain. Aim 1 will examine whether there is specific somatodendritic
connectivity between projection-specific DA populations in the SNc and VTA. Aim 2 will examine the pattern of
somatodendritic connectivity driven by different glutamatergic inputs to midbrain DA populations. Together, these
aims will provide critical information about the circuit organization between midbrain DA neurons and the role of
somatodendritic signaling in shaping output signals. In view of the critical role of the DA system in mediating
important functions and its role in addiction, it is essential that we have a more complete understanding of the
somatodendritic circuitry between dopamine neurons and how these circuits are activated by glutamate inputs.

Public health relevance
Project Narrative Dopamine mediates numerous important functions such as movement, motivation, and reward. The recent discovery that dopamine neurons can inhibit each other in a specific and localized manner, termed somatodendritic signaling, adds a new dimension to the study of dopamine transmission within the midbrain. This proposal aims to understand this pattern of local inhibition between dopamine populations and how excitatory inputs drive this circuitry.